Role of TLR7-mediated B cell activation in primary Sjogren’s syndrome

Project Summary
Sjögren’s syndrome (SS) is an autoimmune disease in which exocrine tissue is damaged, resulting in
loss of tears and saliva. Primary SS (pSS) affects salivary and lacrimal tissue and results in many serious
systemic disease manifestations. Once diagnosis is achieved, no SS-specific curative treatment options are
available; rather treatments for SS are palliative. Thus, there is a critical need to identify etiologic events that will
facilitate earlier diagnosis of SS and development of therapeutics that mitigate the progression of this debilitating
disease. Studies in our laboratory revealed that Myeloid Differentiation Factor Primary Response Protein 88
(MyD88) is essential for pSS development. MyD88 is an adaptor molecule that is expressed ubiquitously and is
required for most Toll-like receptor (TLR) and IL-1 receptor (IL-1R) family member signaling. Notably, TLRs and
IL-1R family members are elevated locally (in salivary tissue) and in peripheral blood cells of SS patients,
suggesting these receptors contribute to SS. The specific ligands and receptors that mediate activation of
Myd88-dependent pathways in pSS have not, as yet, been evaluated in depth. TLR7 is a MyD88-dependent
endosomal TLR that is implicated in many autoimmune diseases, although its role in pSS remains largely
unknown. Our central hypothesis is that B cell-intrinsic TLR7-dependent signaling networks drive pSS
pathogenesis. Our objective is to identify how TLR7 activation of B cells governs pSS disease pathogenesis. We
will employ a pSS mouse model (NOD.B10) and a knockout strain of NOD.B10 mice developed in our laboratory
that lacks expression of TLR7. These mice provide a unique model system to examine the role of TLR7 in pSS
directly. The rationale for this proposal rests on the fact that in lupus, a related autoimmune disease, TLR7
activation of B cells is critical for disease development. Our preliminary data reveal that TLR7 agonism
accelerates pSS development and promotes expansion of age-associated B cells (ABCs), a B cell subset
implicated in autoimmunity in mice and humans, but one that remains poorly understood in pSS. We will test our
hypothesis by completion of two specific aims: (1) Assess TLR7-dependent B cell activation in pSS mice in vitro
and (2) Identify specific B cell subsets that mediate pathology in pSS in a TLR7-dependent manner in vivo. This
study is innovative because it will uncover new mechanisms related to the role of MyD88-dependent signaling
networks in pSS and will identify how TLR7 activation in B cells governs specific disease manifestations. This
proposal is significant because it will reveal new mechanisms that govern chronic inflammation in pSS. Insights
obtained from the proposed studies will reveal novel pathways and specific cell types that can be targeted to
treat pSS and other autoimmune diseases. The fellowship training plan details a comprehensive educational
training experience for the PI, including research experience, development of scientific writing and presentation
skills, and participation in national meetings. The environment at the University of Buffalo is outstanding, as the
Department of Oral Biology has a long history of preparing mentees for successful careers in the oral sciences.

Public health relevance
Project Narrative The proposed project has important implications for public health, as it will address a key mediator of immune dysfunction in Sjögren’s syndrome. We expect this study to result in identification of novel disease mechanisms of immune cell activation that can be targeted to improve the treatment of Sjögren’s syndrome, leading to improved oral and systemic health for individuals afflicted with this debilitating disease.